A Behavioral Intervention to Reduce Psychological Distress Symptoms among Black Gender Minority Women Experiencing Chronic Stigma

A Behavioral Intervention to Reduce Psychological Distress Symptoms among Black Gender Minority
Women Experiencing Chronic Stigma
PROJECT SUMMARY: Black gender minority (GM) women in the United States face a nearly universal
experience of chronic stigma (i.e., enacted, anticipated, and structural stigma), associated with a
disproportionate prevalence of psychological distress symptoms compared to cisgender peers. Psychological
distress symptoms, specifically post-traumatic stress (PTS) and depressive symptoms, can be highly debilitating
and traditional pathways to care are impeded by widespread barriers to healthcare access and engagement for
Black GM women. Such barriers include underprepared healthcare providers, lack of health insurance, medical
mistrust, and high rates of discrimination and victimization within healthcare settings, which have been
associated with increased PTS and depressive symptom severity among Black GM women. Conversely, coping
and GM community connection have been shown to decrease psychological distress symptom severity among
Black GM women. Thus, culturally informed community-based interventions are needed to offset the high burden
of barriers to healthcare and address psychological distress symptoms among this population. The research
objectives of this application are to first, develop a culturally informed community-based intervention with
guidance from community members (via focus groups and theater testing; N=20) to reduce the effect of chronic
stigma exposure on psychological distress symptoms (PTS and depressive symptoms) among Black GM
women. Second, we will conduct a proof-of-concept trial (N=40) to determine the feasibility and preliminary
efficacy of the resulting intervention. Findings will inform intervention optimization to improve symptom
management for this group. The proposed study plays an essential role in developing and evaluating evidence-
based interventions to improve psychological distress symptom management among Black GM women. To
accomplish the proposed research, I propose a research and training program facilitating my transition to an
independent, patient-oriented research career, specializing in symptom science and culturally appropriate
interventions for symptom management that are easily implemented in real-world settings. Research and training
aims will be accomplished through close interdisciplinary mentorship and carefully selected didactic activities,
conference attendance, applied research experiences, and manuscript and grant proposal preparation (i.e., R-
series). Additionally, I will achieve these goals by obtaining clinical and research training in intervention design,
implementation, and evaluation; psychological distress treatment among GM people; and research ethics and
management specific to engaging vulnerable populations. The training plan leverages the well-supported
infrastructure at Emory University, as well as national and institutional opportunities to ensure didactic,
experiential, and specialized individual instruction.
1

Public health relevance
PROJECT NARRATIVE: This research will develop and examine the feasibility and preliminary efficacy of an intervention to improve psychological distress symptom management related to chronic stigma exposure among Black GM women in a community-based setting. The long-term goal of this intervention is to disrupt the complex interacting psychosocial and behavioral factors that exacerbate symptoms of psychological distress with the hope to eventually prevent and/or reduce poor health outcomes in Black GM women experiencing chronic stigma. The proposed study has high public health significance because it plays an essential role in developing and evaluating evidence-based interventions to improve health among a historically disenfranchised group, i.e., Black GM women. 2